Clinical Research Support for the CCR

Current major users of dedicated clinical laboratory service users include the following CCR Branches, Laboratories and Programs: Pediatric Oncology Branch (POB), Surgery Branch (SB), Lymphoid Malignancies Branch (LMB), Vaccine Branch (VB), HIV/AIDS Malignancy Branch (HAMB), Center for Immuno-Oncology (CIO), Urologic Oncology Branch (UOB), Thoracic and GI Malignancies Branch (TGMB), Molecular Imaging Program (MIP), Laboratory of Molecular Biology (LMB), and Laboratory of Human Carcinogenesis (LHC).